Addressing genetic tractability and species-specific infection biology in Chlamydia pneumoniae

ABSTRACT
Chlamydia species represent a paradigm for understanding successful obligate intracellular
parasitism. While C. trachomatis and C. pneumoniae are both prevalent human pathogens, C.
pneumoniae respiratory infections are likely most common. Acute C. pneumoniae infections
manifest as community acquired pneumonia, bronchitis, and sinusitis while additional
inflammatory sequelae are associated with chronic infection. Advances in genetic tractability
have facilitated considerable progress in characterizing C. trachomatis pathogenesis.
Unfortunately, similar progress has lagged for C. pneumoniae, leading to a paucity in details
regarding molecular mechanisms of infection and precluding informative approaches leveraging
comparative studies. To overcome this barrier, we will engineer plasmid systems enabling allelic
replacement and ectopic gene expression for C. pneumoniae. These new technologies will be
applied in proof-of-principle studies to address functional aspects manifested by a pair of
divergent type III secreted effectors employed by C. pneumoniae to manipulate host cell
biology. At the end of these studies, we will have established new approaches that will benefit
the entire Chlamydia research community and advance the understanding of how chlamydial
species have evolved to accomplish common developmental requirements.

Public health relevance
Chlamydia pneumoniae, an agent of human respiratory disease, relies on specialized mechanisms that exert anti-host activities essential to pathogenesis. Understanding those mechanisms requires a tractable means of genetic manipulation. This proposal contains work designed to develop mutagenesis and expression techniques for C. pneumoniae that will be important for the study of disease.